A Small Molecule That Blocks Salmonella Replication in Macrophages

PROJECT SUMMARY
How microbial pathogens evade host cellular defenses remains unclear. A full molecular
understanding of host-pathogen interactions will aid in the development of new approaches to treat
infection. There is a particular need to identify new classes of chemicals that target Gram-negative
human pathogens. We therefore developed an in-cell, high content microscopy-based screening
platform (called SAFIRE) that identifies compounds which prevent the accumulation of GFP-
expressing Salmonella enterica serovar Typhimurium (S. Typhimurium) in macrophages. We are
now at the stage of establishing compound mechanism of action, including defining why compounds
enable the macrophage to survive while the bacterium is killed. The compound we propose to study,
JD1, is not sufficiently developed to be a lead compound for drug development but is instead at the
stage of basic biological discovery. These efforts may reveal new facets of host-pathogen biology,
new targets for Gram-negative bacterial pathogens, and possibly identify a chemical that could be
improved for use as an antimicrobial.
0

Public health relevance
PROJECT NARRATIVE Successful completion of the proposed aims will establish whether a small molecule with anti- bacterial activity in vivo may be a valuable tool to dissect inner membrane biology and the relationship of membrane integrity to bacterial survival in host cells. 0